Orbitrap Exploris 480 Basic System

Project Summary We present our proposal for the acquisition of a Thermo Scientific? Orbitrap? Exploris 480 mass spectrometer that would be installed in the Proteomics Core at the Albert Einstein College of Medicine. This instrument is critical for the performance of proteomics experiments by our NIH funded investigators. Specific projects presented in this proposal that will benefit enormously from this instrument include research on infectious diseases (herpes simplex virus, SARS-CoV2, Toxoplasma gondii, microsporidia, etc.), cancer (myelodysplastic syndrome, molecular regulation and targeting of pre-cancerous and cancer stem cells in hematopoiesis and leukemogenesis), aging (autophagy during aging, neurodegeneration), cardiovascular diseases and fundamental cell biology (obesity, mechanisms of cell death, chromatin, cell signaling). The Einstein Proteomics Core requires this instrument to replace a Thermo Scientific? Orbitrap? Velos. The Orbitrap Velos was acquired in 2010, and it has been the only proteomics-fitted instrument for the Core, but it now needs to be replaced as by the end of 2020 it will no longer be serviced by the vendor. The laboratory space of the proteomics facility has recently been completely renovated and Dr. Simone Sidoli was hired to lead proteomics research at Einstein. In the last year, the proteomics laboratory ran over 2,500 samples from approximately 50 different investigators' laboratories. The Einstein Proteomics Core is also a critical support service for the Einstein Cancer Center, the Nathan Shock Center for excellence on Biology of Aging Research (E-NSC) and the ERC-CFAR Einstein-Rockefeller-CUNY Center for AIDS research.

Public health relevance
Project narrative In this proposal, we request a Thermo Scientific™ Orbitrap™ Exploris 480 mass spectrometer that will be installed and utilized in the Proteomics Core at the Albert Einstein College of Medicine. The Proteomics Core has serviced just in the last year a rapidly increasing number of NIH funded investigators, including 30 laboratories at Einstein and 18 external collaborators to date. At the end of 2020, the only mass spectrometer available in the Core for these type of proteomic projects, a Thermo Scientific™ Orbitrap™ Velos, will no longer be serviced by the vendor due to its old age, so it urgently requires to be replaced.